Slow wave sleep as a biomarker of rehabilitation-induced cognitive improvement in Parkinson's disease

ABSTRACT
Parkinson’s disease (PD) is a neurodegenerative disorder associated with Lewy Body pathology that can lead
to progressive cognitive decline and Parkinson’s disease dementia (PDD), a form of Lewy Body Dementia.
Cognitive dysfunction in PD is common, affecting up to 80% of persons with PD (PwP) over the disease course.
PD-associated cognitive decline has devastating consequences, including quality of life impairment, increase in
caregiver burden, loss of independence and productivity, and increased risk of institutionalization. This results
in significant public health and societal burden. Pharmacologic treatments for cognitive dysfunction in PD are
often ineffective and none prevent progression to PDD. Exercise has promise for improving cognition in PD, but
the best exercise prescription for individual PwP is unknown. Slow wave sleep (SWS) is important for cognitive
function due to its involvement in synaptic plasticity, cortical reorganization, and glymphatic function. The PI’s
preliminary data show that SWS is important for cognitive performance in PwP. Further, the PI found that
exercise increases SWS in PD and only PwP with increased SWS had improvement in executive function. This
interindividual response heterogeneity provides an opportunity to tailor exercise prescriptions to individual PwP.
The hypothesis is that exercise will improve cognitive function in PD and that changes in SWS will serve as a
biomarker and mediator of rehabilitation-induced cognitive response. Our exploratory hypothesis is that
efficiency of glymphatic function may underlie these effects.
Using an innovative Sequential Multiple Assignment Randomized Trial (SMART) design, the PI will test these
hypotheses in a randomized, controlled trial of 120 PwP to investigate 1) the effects of exercise rehabilitation
versus delayed-exercise control on cognition in PwP (Aim 1); 2) determine if changes in SWS due to exercise
mediate the exercise-induced changes in executive function in PwP (Aim 2); and 3) determine if glymphatic
function predicts exercise-induced changes in cognition (Exploratory Aim).
Study design: In the first phase of the trial, participants will be randomized to 12-weeks of progressive resistance
training rehabilitation (PRT) or delayed-exercise control (1:1). Arm assignment in the 2nd 12-week phase of the
trial will be determined by individual response in the first 12 weeks. Specifically, responders (those with increases
in SWS) will continue PRT for the 2nd 12 weeks of the trial while non-responders (no sufficient increase in SWS)
will transition to endurance training (ET) for the 2nd 12 weeks. After the 1st 12 weeks of the trial, participants in
the delayed-exercise group will perform PRT for the 2nd 12 weeks of the trial. The study addresses priority areas
of NCMRR by investigating 1) an objective marker (SWS) that may predict individual rehabilitation treatment
response and 2) treatment for secondary conditions (cognitive impairment) associated with physical impairment
(Parkinson’s disease).

Public health relevance
PROJECT NARRATIVE Persons with Parkinson’s disease (PwP) frequently experience cognitive dysfunction, which has a profound negative impact on quality of life and daily function and thus increases public health burden. Pharmacologic therapies are often ineffective for treating cognitive dysfunction in Parkinson’s disease and no medications are known to halt cognitive decline. This study will investigate deep sleep as a marker of rehabilitation-induced improvement in cognition in Parkinson’s disease to guide selection of the optimal exercise prescription for individual PwP.